Deciphering the mechanisms regulating itaconate production and signaling in macrophages

PROJECT SUMMARY
Macrophages are innate immune cells that serve diverse roles in host defense, tissue repair, and homeostasis
which are crucial to systemic physiology in all tissues. Therefore, dysregulation of macrophage function can
contribute to a wide range of pathologies, including chronic inflammation, metabolic diseases, and cancer.
Mitochondrial metabolites have been identified as important regulators of macrophage function with one key
regulatory mode involved in post-translational modification (PTM) of cysteine residues on protein targets, which
invokes changes in protein structures and functions. Within the past decade, itaconate has emerged as a crucial
immunomodulatory metabolite in macrophages. Itaconate is uniquely produced in myeloid cells, most notably in
macrophages, by a mitochondrial enzyme named aconitate decarboxylase 1 (ACOD1) and can directly modify
protein targets in macrophages via a cysteine PTM called alkylation. However, the breadth of the cysteine targets
subjected to this PTM at the proteome level in macrophages is unknown. No study to date has identified the
mechanism by which ACOD1 enzyme activity is regulated. Through extensive preliminary studies, I have
stoichiometrically defined the macrophage cysteine proteome undergoing itaconate-mediated alkylation by
utilizing a high-throughput redox proteomic platform called mass spectrometry-based cysteine-reactive
phosphate tag (CPT-MS). From this cysteine proteomic dataset, I’ve discovered a cysteine site on ACOD1 that
is potently modified by itaconate. Through preliminary in vitro ACOD1 enzyme activity assays, I’ve demonstrated
that the identified cysteine site is important for ACOD1 enzyme activity and that itaconate can inhibit its own
production by antagonizing ACOD1 activity. Building on these preliminary data, I hypothesize that itaconate
production is involved in a feedback mechanism by which itaconate alkylates crucial cysteine site(s) on ACOD1
to control enzyme activity by invoking structural changes. Using a combination of crystallography, protein
biochemistry, and in vivo/in vitro CRISPR editing, I aim to 1) decipher this self-regulatory mechanism
underpinning itaconate production and 2) determine the physiological importance of the ACOD1 cysteine residue
identified from my CPT-MS data. The findings from this proposed work will uncover a unique mechanism of
itaconate production and signaling in macrophages. Moreover, the results of this proposal will lay the foundation
for the design of the first-in-class ACOD1 inhibitor/activator and other molecular effectors by targeting key
cysteines to manipulate macrophage function in all macrophage-related disease contexts. Additionally, I propose
a detailed training plan under this fellowship to provide me with the practical and conceptual skills that will help
me complete this project and benefit my future career goals to be an independent scientist. This project involves
a wide range of interdisciplinary science to which the excellent environment at Dana-Farber Cancer Institute and
Harvard Medical School can provide me with the opportunity to collaborate with many experts in the fields who
can give me the necessary support and training to complete my proposed aims.

Public health relevance
PROJECT NARRATIVE Macrophages are highly plastic innate immune cells that play many crucial roles in host defense, tissue repair, and homeostasis. Due to these diverse functions, dysregulations of macrophages often contribute to the hallmarks of a wide range of diseases including chronic inflammation, metabolic diseases, and cancer. My proposed project aims to understand how metabolite signaling controls macrophage function through protein- metabolite interactions, which can be leveraged to design novel therapeutic approaches to manipulate macrophage activity for the treatment of all diseases characterized by macrophage-mediated inflammation.